Circadian control of nutrient-sensing and fuel utilization in skeletal muscle

? DESCRIPTION (provided by applicant): Circadian systems play a central role in energy harvesting and storage across daily cycles of fuel availability in nearly all organisms. In vertebrates, clock genes promote metabolic constancy by coordinating the phase and expression of genes involved in glycolytic and oxidative metabolism. Genetic studies demonstrate that the clock network exerts alternating effects on physiology at different times of day in a tissue-specific manner. A major clue concerning the role of the clock signaling network during fasting and nutrient deprivation stems from our recently published discovery (Science, 2013) that circadian transcription factors directly control cellular levels ++ of NAD and activity f NAD -dependent metabolic regulators. We have uncovered a novel pathway by which ++ the circadian clock control of NAD impacts mitochondrial metabolism through rhythms of NAD -dependent processes, including protein deacetylation via the mitochondrial sirtuin SIRT3. However, it is still unclear whether the circadian clock controls daily transitions of oxidative an glycolytic fuel utilization in all metabolic tissues, and whether abrogation of this pathway leads o impaired whole animal metabolic physiology. To address this question, I propose to dissect the role of circadian factors in metabolic fuel handling and the response to nutrient stress (e.g. exercise, fasting) in skeletal muscle, a tissue that undergoes dramatic daily fluctuations in nutrient availability due to rhythmic behaviors such as feeding and locomotor activity. Specifically, I propose to focus on the interplay between circadian clocks and two key nutrient stress response + pathways: the NAD /sirtuin axis and the hypoxic stress response (HIF) transcriptional network. The overarching goal for this application is to provide new insight into the homeostatic link between biological timing and nutrient sensing pathways with implications for the treatment of metabolic disease including skeletal myopathy and diabetes.

Public health relevance
PUBLIC HEALTH RELEVANCE: The escalation of metabolic disease, including obesity and type 2 diabetes mellitus, has emerged as a worldwide public health challenge, and increasing evidence indicates that susceptibility to these disorders are increased in people who disrupt their daily sleep/wake fasting/feeding cycles, as is often the case for shift or night workers. To advance our understanding of the link between circadian rhythms and metabolism, I propose to dissect the molecular pathways that provide 'crosstalk' between circadian and metabolic processes in animal tissue. The overarching goal of this application is to understand the molecular mechanisms underlying circadian timing of metabolism and to advance our knowledge of metabolic disease.